Artificial Intelligence, Biomedical Informatics, and Data Science (AIBIDS)

The University of Pittsburgh (Pitt) and Gallaudet University (GU) will partner to create the Artificial Intelligence, Biomedical Informatics, and Data Science (AIBIDS) program which will help excelling undergraduate and masters students on their journey to becoming leaders in the application of computing to improving human health. AIBIDS is a partnership between the Pitt Department of Biomedical Informatics Training Program, founded in 1987 and one of the strongest biomedical informatics PhD training programs in the country, and the GU Science, Technology, Accessibility, Mathematics, and Public Health (STAMP) program, which has been producing world-class STEM baccalaureate graduates who are DHH since 1864. The program has two separate sites to broaden the research and mentoring opportunities for all students. Specific Aim 1: Provide authentic and rigorous mentored research internships with experienced faculty and near-peer mentors to an excelling group of undergraduate and Masters level students. Specific Aim 2: Refine and develop curricula to support the academic, scientific, and professional development of students throughout the summer through continuous engagement. The AIBIDS program will provide students training and research skills necessary for them to more quickly obtain PhDs in biomedical informatics and data science, enabling them to drive the next generation of research questions and lead advances that benefit human health. The AIBIDS program will apply rigorous evaluation methods to measure the progress of participating students towards advanced biomedical informatics careers in industry and academia.

Public health relevance
The University of Pittsburgh (Pitt) and Gallaudet University (GU) will partner to create the Artificial Intelligence, Biomedical Informatics, and Data Science (AIBIDS) program which will help excelling undergraduate and masters students on their journey to becoming leaders in the application of computing to improving human health. The AIBIDS program will provide students training and research skills necessary for them to more quickly obtain PhDs in biomedical informatics and data science, enabling them to drive the next generation of research questions and lead advances that benefit human health. The AIBIDS program will apply rigorous evaluation methods to measure the progress of participating students towards advanced biomedical informatics careers in industry and academia..